Coordinating Center of the Claude D. Pepper Older Americans Independence Centers

Abstract
Led by Wake Forest School of Medicine since its inception in 2005, the Coordinating Center (CC) for the NIA-
funded Older Americans Independence Centers (OAIC) Program has become a dynamic force for initiating,
facilitating, and coordinating activities that maximize interactions and collaborations within the OAIC network
and between the OAIC network, other NIA programs, and the aging research community. During this funding
cycle, the CC has fostered dramatic growth in the number and impact of OAIC collaborative projects. With this
cycle, the CC will be awarded as a U24 cooperative mechanism with enhanced funding to pursue new
initiatives and build on CC accomplishments. This proposal will take advantage of these positive changes to
further enhance the impact of the OAIC program with the following 4 bold Specific Aims, each of which
includes several innovations and new initiatives, and which were informed by our preliminary data, including
semi-structured interviews with each OAIC director and with NIA program officers. Aim 1. Enhance
communications and coordination within the OAIC program and with the greater aging research
community. Aim 2. Facilitate and promote OAIC-themed collaborative research. Aim 3. Enhance the
development of the next generation of researchers in aging. Aim 4. Establish a process for
accelerating dissemination and implementation of key OAIC research findings.
Our aims will be achieved by: 1) building on our 12 years of experience and earned trust in progressively
building collaborations; 2) adding several innovative strategies to our current array of well-functioning programs
and processes; 3) expanding our dynamic leadership team (below); 4) obtaining regular input and guidance
from the OAIC Directors Committee and the NIA program office; 5) empanelling 4 working groups to assist in
carrying out each of the Aims; and 6) utilizing a formal, structured plan to continually evaluate progress toward
each aim and the overall program.
The CC will be led by a cohesive team of highly experienced OAIC leaders with complementary skills and well-
defined roles: Dalane W. Kitzman, MD, project PI, associated with the CC since its inception and Director since
2015; Michael Miller, PhD, a CC co-investigator since its inception; Karen Bandeen-Roche, MD (Johns
Hopkins), leader for Aim 3; Jeff Williamson, MD, MHS (Wake Forest), leader for Aim 4, and Nicholas Pajewski,
PhD, junior faculty `leader-in-training' for Aim 2.
This proposed renewal of the CC will further enhance and extend OAIC collaboration, provide vital new
translational opportunities, particularly for junior faculty, promote development of new investigators, and
disseminate key OAIC research findings to positively influence the care of older Americans.

Public health relevance
Narrative Led by Wake Forest since 2005, the Coordinating Center (CC) for the Pepper OAIC Program builds collaborations that produce synergy within the OAIC network and the aging research community. In this cycle, the CC fostered dramatic growth in the number and impact of OAIC collaborative projects. This proposal, led by a cohesive team of highly experienced OAIC leaders with complementary skills, will take full advantage of the increased funding provided in the new RFA to further enhance and extend the impact of the OAIC program by executing 4 bold Specific Aims, each with several innovations that were informed by our preliminary data.